IU training Program in Molecular Physiology and Clinical Mechanisms of Lung Disease

? DESCRIPTION (provided by applicant): This T-32 Training application is to competitively renew the current T32 pulmonary training program, anchored within the Indiana University School of Medicine, the only medical school in the state of Indiana. The proposed program builds on the success of the current training award, being multidisciplinary, highly collaborative, and including established investigators and highly qualified and dedicated mentors. We will continue to expose trainees to classical elements of basic and clinical-translational research, to which we incorporated novel technologies and a robust component of regenerative medicine, building on our local strengths. New in this application is a partnership with Pediatric Pulmonology at IU, fueled by the realization that adult lung diseases start in childhood or even prenatally, and by the strong history of cross training our fellows in research. Given the success and growth of our program, we are also proposing an increase in the number of trainees, adding one predoctoral and one postdoctoral spot to the three postdoctoral positions from the current program. The addition of one predoctoral position will also allow us to more efficiently to recruit future leaders of pulmonary and critical care medicine at an early stage. Finally, we propose to offer to interested postdocs a track for training in life science entrepreneurship, as an alternatie but yet important science career track. The ultimate goal is for us to train investigators that wil accelerate the advancements in lung research and close the gaps in knowledge that prevented for so many decades the development of phenotypic characterization, effective preventive intervention, and disease-modifying or even curative druts for most patients with lung disease. We maintain the strong commitment to training underrepresented minority talent and by a strong oversight from leaders in the field.

Public health relevance
We propose a training plan for one predoctoral student, two pulmonary physicians and two PhD scientists to become outstanding researchers or entrepreneurs in both Adult and Pediatric Pulmonary and Critical Care Medicine, which studies lung diseases such as COPD/emphysema, pneumonia, asthma, acute lung injury, lung transplant, pulmonary hypertension, as well as cystic fibrosis, BPD, and early origins of adult lung disease. There is a high requirement to train experts who will discover new management tools needed for lung diseases which contribute to a high mortality in the US and our program is designed to address this need.